Engineering a Vascularized Brain-Chip for Probing and Evaluating Mechanisms of Alzheimer’s Disease

An estimated 1 in 10 Americans age 65 and older are currently living with Alzheimer’s Disease (AD), yet there
is still no pharmacologic treatment available that can slow or stop the neuronal damage in AD. A number of drugs
targeting AD that showed promising results in mice have failed to prevent cognitive decline in clinical trials. We
still do not understand the molecular mechanisms underlying AD and current in vitro systems fail to recapitulate
the complexity of the disease. An in vitro human brain model that recapitulates AD pathology could enable the
elucidation of mechanisms of AD and provide a tool for drug testing and discovery for improved clinical outcomes.
Recently, collaborator Li-Huei Tsai developed a model of the brain with all seven relevant neural cell types
(miBrain). Engineering a brain-mimetic hydrogel scaffold and introducing flow into the system are desired to
enhance the physiological relevance and cell phenotypes. A novel brain-mimetic hydrogel scaffold will be
engineered, which, unlike current alternatives, will not contain deleterious extracellular matrix (ECM) components
like fibrinogen and will have tunable degradation kinetics and less batch-to-batch variability. iPSC technology
will be used to create models that each contain cells from a single individual and that will be created for individuals
from diverse genetic backgrounds. Combining iPSC technology and a brain-mimetic scaffold in a perfusable
platform, will result in a system that could enable the study of AD mechanisms and evaluation of therapeutic
treatments. This model will be deployed to interrogate the pathway involving APOE4-promoted pathogenesis,
the strongest genetic risk factor for late-onset AD, assessing the impact of APOE variant and key molecular
regulators on AD pathological signatures. The model will be further harnessed to assess the effect of ECM
components on AD pathogenesis and profile changes in ECM, as AD is associated with changes in AD but
heretofore there has not been an in vitro model to probe the effects or causes of these changes.
This work will result in the development of a novel perfusable miBrain model that can be harnessed to study and
test therapeutics for AD, dissecting underlying molecular pathways and assessing disease pathogenesis and
neuronal activity. The combined hydrogel scaffold, chip platform, and iPSC technology provide a powerful
approach to mimicking the brain that can be rapidly deployed to probe a broad variety of questions related to
neurovascular mechanisms, neural cell type interactions, and neurological diseases.
For training, this project enables the synthesis of fields, combined in ways that lead to gaining new expertise in
each area while developing a novel research niche with many potential future directions. The project will be
executed in a world-renown training environment and with a comprehensive training plan that includes helpful
techniques, courses, conferences, seminars, journal clubs, and lab and individual meetings. This is all designed
to launch an academic scientist career of developing technologies that enable probing neurobiological
mechanisms, therapeutic discovery, and improved disease treatments and of training future scientists.

Public health relevance
PROJECT NARRATIVE We do not yet have a treatment for Alzheimer’s Disease improves cognitive outcomes and the underlying disease mechanism remains unknown. I propose to engineer a miBrain-chip model of the brain and harness it to recapitulate the hallmarks of Alzheimer’s Disease pathology in vitro, probe the effect of genetic risk factor APOE and ECM changes on pathology progression, and evaluate the underlying mechanisms. This novel work will provide insights relevant to Alzheimer’s treatments and result in the development of a readily interrogable and monitorable platform that can be deployed for therapeutic testing, addressing many mechanistic questions, and probing other neurological diseases.